The X-VISUAL (X-ray Visualized Indicator for Screw-strain Under Applied Load)

ABSTRACT
We are developing and sensor, the X-VISUAL (X-ray Visualized Indicator for Screw bending Under Applied
Load), to track fracture healing in canulated screws used to treat hip fractures. Hip fractures are a major public
health concern with high in-hospital mortality rate. Approximately 330,000 hip fixation procedures are
performed annually in the US. The average hip fixation hardware failure rate is around 5%, but increases to
over 20% in patients with comorbidities such as osteoporosis, unstable fractures and poor initial fracture
reduction. When healing is delayed, the screw, other hardware, and bone can fatigue and fail, requiring costly
revision surgery with significant risk of morbidity and mortality for these frail patients. For example, the 1-year
all-cause mortality rate for patients readmitted within 30 days of surgery is 56%, compared to 19% for those
not readmitted. Screws only bend and cutout when they are loaded, and this risk disappears as a fracture
callus heals and carries the load. Thus, measuring screw bending under standing load is an ideal way to
assess fracture healing and risk failure. This improves communications with the patient and care team,
enabling normally healing patients and physical therapists to feel more comfortable with activity, while
detecting and avoiding pathologies for slowly healing patients. Innovatively, the X-VISUAL is the first sensor
that can detect screw bending (and associated load on the screw), a measurement that is hard to perform in
other ways because of the confined geometry. The patent protected device is designed to load into a screw
after guidewire removal, and is read using plain radiography which is ubiquitously available in healthcare
facilities but is usually insensitive to mechanical strain and usually detects pathologies when they have
progressed so far that non-surgical interventions often don’t work. Using previous designs we demonstrated
proof of concept for measuring screw bending with X-rays in Sawbones specimens, FEA models, cadaveric
specimens, and tracked healing in a sheep. However, the old designs were cumbersome to insert and read,
thus this Phase I proposal designs an elegant addon with a gain mechanism and readout on indicator along
the pin. We will develop and test the design in FEA computational models, sawbones, and cadaveric
specimens. The clinical, industry, and academic partners assembled for this work have a strong history of
collaboration in orthopaedic device development and testing. They bring together expertise in measurement
systems, mechanical testing, medical device design and orthopaedic surgery. The research is relevant to
public health because, it provides a non-invasive means of assessing biomechanical reduction and postop
fracture healing to avoid costly and risky revisions.

Public health relevance
Project Narrative This research project develops a novel sensor that inserts into cannulated orthopedic screws and indicates screw bending using plain radiography to track fracture healing. The research is relevant to public health because it provides objective metrics to assess fracture stability and healing in individual patients in order to prevent catastrophic implant failure with high associated mortality especially in frail patients.